DAPSONE AND ATOVAQUONE STUDY FOR PCP IN HIV INFECTED PATIENTS

This study was designed to compare the efficacy and safety of daily dapsone versus daily atovaquone suspension in the prevention of pneumocystis carinii pneumonia (pcp) amount HIV-infected patients at high risk for pcp and with a history of intolerance to trimethoprim and/or sulfonamides (tmp/smx, bacterium/sptra). The study was initiated in october 1995 and patients were followed to a common closing date of April 11, 1997. Pcp and vital status on this closing date were verified by clinical sites during April, May and June.